Discovering New HIV-1 Latency Reversal Agents from Euphorbia Species

PROJECT SUMMARY
Antiretroviral therapy (ART) has rendered HIV-1 infection a treatable illness, however ART is not curative due
to replication-competent untranscribed provirus in long-lived resting T cells. Strategies to directly target these
latently infected cells will be necessary to eradicate the virus in people living with HIV-1 (PLWH).
Pharmacologic approaches using compounds to reverse viral latency (known as latency reversal agents or
LRAs), to subject the reservoir to immune-targeting or clearance via viral cytopathic effects, have been studied
in clinical trials. No trial to date, however, has significantly perturbed the latent reservoir. One major barrier
impeding progress toward HIV-1 eradication is the identification and characterization of LRAs that are able to
reactivate a significant fraction of the latent reservoir and do not have adverse effects that would limit in vivo
use. One mechanism of latency reversal, protein kinase C activation, has shown promise in vitro, as well as in
murine and non-human primate models of HIV-1 latency. Given the unfulfilled and urgent need for effective,
scalable HIV-1 cure strategies, the potent latency reversal induced by PKC agonists in vivo presents an
attractive approach. We and others have identified the latency reversal potential of PKC agonists known as
ingenols, naturally-occurring compounds common to a family of medicinal plants known as Euphorbiaceae.
Euphorbia kansui, for example, is native to east Asia and contains 14 unique ingenol compounds with PKC
agonist activity. The root powder of E. kansui, formulated as tea, is used in Traditional Chinese Medicine as a
cathartic to treat fluid overload and constipation. We have been conducting a first-in-human, phase I clinical
trial evaluating safety, anti-latency and immune stimulatory effects of E. kansui tea among PLWH
(NCT02531295) that has proven to be safe and well-tolerated. Ingenol mebutate, a naturally-occurring ingenol
present in E. peplus, is FDA-approved for topical use to treat actinic keratosis. A recent report described HIV-1
latency reversal in vivo among PLWH using ingenol mebutate. Many Euphorbia species native to East Africa, a
region disproportionately affected by HIV-1, are in active use as traditional medicines. However, little is known
regarding potential anti-HIV-1 or immune modulatory activities of these natural products or their chemical
constituents. We hypothesize that chemical components of Euphorbia species in active use as traditional
medicines have potent HIV-1 latency reversal activity. We propose a complete pre-clinical characterization of
naturally-occurring bioactive compounds isolated from medicinal Euphorbia plant species native to East Africa,
with regard to latency reversing potential, immune perturbation, and potential off-target effects in vitro and in a
murine model of HIV-1 persistence. This work will generate new knowledge to inform strategies aimed at
elimination of the HIV-1 latent reservoir.

Public health relevance
Project Narrative Antiretroviral therapy suppresses, but does not cure, HIV-1 infection due to the persistence of dormant proviruses within long-lived cellular reservoirs. This proposal seeks to discover new approaches to awaken these latently infected cells by studying a library of medicinal plants, members of the Euphorbia family, that are in active use in East Africa as traditional medicines. This new knowledge will have a positive impact on our ability to directly target latently infected cells, which in turn will help to inform the design of clinical trials aimed at HIV-1 eradication.